Preeclampsia and the Brain: Small vessel disease and cognitive function in early midlife

Cerebral small vessel disease (cSVD) predisposes to vascular cognitive impairment and dementia, including
Alzheimer’s Disease. Preeclampsia (PE), a pregnancy-specific disorder with acute hypertension and placental
SVD, is emerging as a sex-specific risk factor for dementia later in life. How PE is implicated in the etiology of
dementia is not known. Women with PE have SVD also in other vascular beds, including the brain, after
pregnancy and worsening with older age, suggesting this process evolves over time. However, studies on SVD
in midlife are sparse. Midlife is an ideal time to assess this risk as PE-differences in cognition are already
detectable, and yet there is time to mitigate progression to dementia. Cerebral SVD (cSVD) in midlife may hold
the key to understand how PE is implicated in cognitive impairment.
Placental SVD, known as maternal vascular malperfusion (MVM) predicts worse short-term pregnancy
outcomes. We find MVM and PE combined predict long-term worse maternal vascular health in cardiac,
sublingual, and cerebral beds. In our pilot study (n=24) MVM and PE combined predicted lower
cerebrovascular reactivity (CVR, an early stage of cSVD), especially in fronto-parietal areas; in turn, lower CVR
in these regions was associated with, and appeared to explain, PE-related worse cognition.
Importantly, these
findings were independent of hypertension, suggesting PE has direct and lasting vascular effects
. PE and
MVM may be early indicators of a future cerebrovascular phenotype, manifesting in midlife as lower CVR, and
may explain how PE affects cognition. We propose to study midlife women with and without prior PE to: 1)
Characterize the neural basis of PE-related poorer cognitive performance, 2) Assess whether placental SVD
(MVM) predicts cSVD and cognition, and 3) Explore whether sublingual SVD and circulating markers of SVD
are markers of cSVD and cognition.
We propose a neurocognitive study to capture early stages of cSVD and cognitive status in a racially diverse
cohort of
450
women (1:1 PE and non PE) from our ongoing WINDOWS study, mean age=45, 15 years post-
pregnancy, 30% black, with existing data on PE, MVM, and sublingual SVD 10 years after pregnancy. We will
use our advanced multimodal neuroimaging protocols to quantify cSVD (including CVR, blood flow,
connectivity), standardized validated protocols to measure cognition, and non-invasive markers of SVD
(sublingual SVD, and
circulating biomarker profiles)
. Our project is uniquely positioned to identify a previously
occult high-risk group that can be identified at delivery by placental pathology, and who may benefit from risk-
stratification for dementia, to mitigate or delay disease progression.

Public health relevance
Project Narrative Preeclampsia, a pregnancy-specific disorder characterized by hypertension and placental small vessel disease (SVD), is emerging as a sex-specific risk factor for dementia later in life; reasons for this elevated risk are unknown, and prevention or treatments are unavailable. We propose preeclampsia with placental SVD predicts higher probability of cerebral SVD and impaired cognition in midlife, independent of cardiovascular factors.